Ultra-small scale assay of enzyme inhibition for drug discovery

Project Summary
Lipid pathways are recognized as critical to cell function and survival and are crucial in disease states.
Targeting the lipid-processing enzymes in these pathways has become increasingly important and
promising in a wide range of diseases, including cancers, autoimmune, and neurological diseases. For
example, there are currently >40 pharmacologic drugs targeting the sphingolipid pathway alone in clinical
trials or in clinical use for oncology and autoimmune diseases. Despite their importance, massive gaps
exist in our understanding of these pathways due to technical limitations in measuring the biochemical
activity involved in lipid signaling, particularly in a high-throughout, highly sensitive, and cost-eﬀective
approach. To meet this need, Piccolo Biosystems Inc., an early stage biotechnology company, will
collaborate with scientists at the University of Washington to develop and validate an innovative assay for
measuring and targeting an important drug target sphingosine kinase (SphK) in cancer cells. Piccolo will
leverage our patent-pending technology - the Picoliter-scale Thin Layer Chromatography (pTLC) platform
to enable the assays of lipid-modifying enzymes in an automated fashion. In this Phase I SBIR, this
collaboration will validate the sample transferring workﬂow to ensure the repeatable spoQing of pL-
volume samples, optimize lipid separation conditions, and validate the in vitro assay conditions with a
focus on quantitative strategies to benchmark performance. While this proposal speciﬁcally focuses on
SphK for cancers, the validated workﬂow will enable high-content/high-throughput assays in a rugged
and reproducible manner.

Public health relevance
Project Narrative The novel sphingosine kinase (SphK) assay will have a wide-ranging impact on high-throughput drug screening and precision medicine, and have broad applications in many areas where miniature specimens and parallel analyses are desired, such as diagnosis of diseases, cell heterogeneity analysis, monitoring droplet-based reactions, and detecting miniature environmental, food, forensic, and pharmaceutical samples.